At-home gait-cadence functional assessment and recovery trajectory for older adults undergoing major abdominal surgery

ABSTRACT
Over 100,000 older adults undergo elective major abdominal surgeries in the US each year and many
experience loss of mobility after surgery. Risk of mobility loss is greater for older adults unable to engage in
moderate-intensity physical activity before surgery. Identifying at risk older adults pre-operatively is critical as
functional status is modifiable before surgery through multimodal pre-habilitation. However, objective functional
assessments of older adults are not routinely performed before surgery in part due to time. Gait-cadence is
directly associated with activity-intensity and can be quickly and easily measured by smartphone
accelerometers, making it a novel measure to remotely assess preoperative functional status. Our central
hypothesis is that gait-cadence during usual and fast pace walks at-home will 1) provide an accurate and easy
to use functional assessment 2) identify patients at-risk of mobility loss as compared to the currently used 6-
minute walk test (6MWT) and overall daily active time and 3) determine walking recovery trajectories for older
adults after surgery. The overall objective of this proposal is to validate the accuracy and usability of at-home
gait-cadence assessment using patient owned smartphones before surgery and determine recovery
trajectories after surgery in older adults. We will achieve this objective with the following three aims: 1)
Determine the accuracy and usability of at-home gait cadence assessment. We will compare at-home gait-
cadence during usual and fast pace brief walks performed remotely and independently at-home to in-clinic
equivalents. Gait-cadence will be measured using open-source accelerometer analysis software which
represents a significant innovation from traditional approaches that use native software from commercial
wearable devices. 2) Determine the association between at-home gait-cadence, in-clinic 6MWT distance, and
daily active time. We will compare at-home gait-cadence to 6MWT distance which is currently used to identify
older adults at high perioperative risk. Actigraph accelerometers will be worn for 7-days prior to surgery to
identify patients that engage in moderate-activity intensity. 3) Determine walking recovery trajectories for older
adults after surgery. Patients will perform the usual and fast pace walk using Step Test weekly for two months
after discharge and evaluate trajectories of walking recovery after surgery. The professional development plan
combined with the completion of these aims is the necessary first study for further research (K awards) that
identify high-risk patients for mobility loss using gait-cadence and test a walking pre-habilitation program to
improve mobility after surgery for older adults.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it focuses on validating at-home gait-cadence as a preoperative functional assessment to identify older adults at risk of mobility loss after major abdominal surgery. Once validated there is potential to identify at-risk older adults early in the preoperative period to engage them in multimodal pre-habilitation and improve mobility after surgery, an important patient centered outcome. This proposal directly aligns with the National Institute of Aging’s goal C-2 to develop improved approaches for early detection and diagnosis of disabling illnesses and age-related debilitating conditions.